Novel role of APOBEC3 enzymes as key mediators of cisplatin sensitivity through aberrant processing of interstrand crosslinks

Cisplatin has been used clinically to treat a variety of cancers for nearly four decades. Along with second and
third generation platinum analogs, it is still one of the most widely used chemotherapeutic drugs with over four
billion dollars in annual sales. Despite its wide use, clinical limitations including drug toxicity to normal cells and
the development of drug resistance in cancers has limited the impact on cancer treatment. Understanding how
to overcome these clinical limitations is critical for achieving better cancer responses and increasing overall
patient survival. To this end, we have established a novel mechanistic model in which two specific DNA repair
pathways, base excision repair (BER) and mismatch repair (MMR), work in conjunction to mediate cisplatin
efficacy. This mechanistic model is based on the specific cis/carboplatin DNA interstrand crosslink (ICL)
structure in which extrahelical cytosines that flank the ICL are targets for deamination. In this proposal, we
have novel preliminary data that supports a family of proteins, APOBEC3 cytidine deaminases, in initiating the
deamination of the extrahelical cytosines adjacent to the cisplatin ICLs and activating the BER pathway.
Following deamination of the cytosines to uracil, the BER pathway is initiated by uracil DNA glycosylase (UNG)
cleavage to produce an abasic site that is subsequently processed by AP endonuclease (APE1) to cleave the
phosphodiester backbone adjacent to the cisplatin ICL. Polymerase beta (Polβ) is recruited to the 3'-OH site
and synthesizes DNA downstream of the cisplatin ICL, but with poor fidelity. We were the first to demonstrate a
dependence on Polβ nucleotide misincorporation to activate MMR, which ultimately inhibits productive ICL
DNA repair and maintains cisplatin sensitivity. In our preliminary data, we demonstrate a dependence on
APOBEC3 expression to mediate cis/carboplatin sensitivity and activate the BER response. This is further
supported by clinical data in which high APOBEC3 expression can mediate a clinical response to cisplatin. We
also demonstrate that mutations in Polβ that affect polymerase activity result in hypersensitivity to cisplatin as a
consequence of enhanced inhibition of ICL DNA repair. This suggests that the clinically relevant mutations in
Polβ, which have been observed in ~30% of tumors tested, that alter polymerase function (e.g., decreased
catalytic activity and/or decreased fidelity) may be beneficial for better clinical response to cis/carboplatin
treatment as a result of the futile processing of cis/carboplatin ICLs. Here, we propose to (i) elucidate the
APOBEC3 family members involved in cisplatin sensitivity and ICL cytosine deamination, (ii) assess the
interplay between APOBEC3 members and BER/MMR proteins in cisplatin ICL processing and (iii) identify
clinical Polβ mutations that mediate cisplatin efficacy and determine the dependence on APOBEC3 activity.
Therefore, this project will provide a comprehensive mechanistic model for how APOBEC3 proteins activate
BER/MMR to maintain cis/carboplatin efficacy and help establish a new paradigm in cis/carboplatin
chemotherapy utilizing specific Polβ mutations and altered APOBEC3 expression for patient stratification.

Public health relevance
Narrative Cisplatin and other platinum-based chemotherapeutic drugs are still the mainstay treatment for many cancers. Clinical limitations, however, including cancer drug resistance, are a major health concern. The goal of this proposal is to assess the mechanism of how APOBEC3 deaminases activate BER and MMR to mediate cisplatin efficacy. Understanding the interplay between these pathways will help identify patients that will respond better to cisplatin chemotherapy as well as assist in the design of new treatment protocols in cancers.